3D Human neurocircuits to determine the role of microglia in AUD and Alzheimer's neuronal pathology

Abstract: 3D human neurocircuits to determine the role of microglia in AUD and Alzheimer’s neuronal
pathology. Altered neuronal metabolism, neuronal activity, and neurodegeneration are key features in both
alcohol use disorder (AUD) and Alzheimer’s disease (AD). AUD and AD are linked, with alcohol related brain
damage (ARBD) being one of the strongest risk factors for AD. However, the mechanisms underlying altered
neuronal metabolism in these diseases, and its impacts on neuronal activity and neurodegeneration are
unknown. We reported that proinflammatory microglia promote ARBD and alcohol-enhancement of AD
pathology. We now find that microglia promote lipid accumulation in neurons with alcohol. Therefore, we
hypothesize that alcohol alters neuronal activity and survival to promote AUD and AD through a novel microglia-
neuronal metabolic link. In AUD and AD, brain glucose metabolism is reduced. ARBD correlates with this
reduction, suggesting metabolic changes promote pathology. Recent studies suggest microglia may also
contribute. Proinflammatory microglia undergo a glycolytic burst that can produce high levels of lactate and
express the lactate exporter MCT4. We hypothesize that the proinflammatory microglia induced by alcohol
deliver excess lactate to neurons, causing a metabolic imbalance that alters neuronal activity and promotes
neurodegeneration. Alcohol (i.e. ethanol) is metabolized by oxidative and non-oxidative pathways (OME and
NOME) to produce acetate and fatty-acid ethyl esters (FAEEs) respectively. Acetate is converted to lipids
through acetyl-coA. Microglia, but not neurons, have OME machinery. Thus, we hypothesize microglial OME
releases acetate to disrupt neuronal lipid metabolism. We recently found that accumulation of neuronal lipids
caused by alcohol promotes AD pathology. Amyloid-β (Aβ) is normally degraded within neurons by lysosomes.
Ethanol increased neuronal lysosomal lipid to cause lysosomal damage and prevent neuronal degradation of
intraneuronal Aβ. Inhibition of proinflammatory microglia prevented neuronal lipidosis, identifying microglia as
regulators of AD-promoting changes in neuronal metabolism. However, the mechanism underlying this microglia-
neuronal link in AD are unknown. Given the impact of ethanol on microglial activation, and consequences of
ethanol metabolism, we hypothesize energetic metabolites produced by microglial glycolysis as well as microglial
ethanol metabolism combine to produce neuronal lipidosis, lysosomal dysfunction, altered neuronal activity, and
neurodegeneration associated with AUD and AD. We propose to employ novel human 3D reciprocal brain
circuits (h3D-rC) to test the role of microglia in neuronal metabolism and activity (Aim 1-2), alcohol-induced
neurotoxicity (Aim 1) and Aβ accumulation (Aim 2). These reciprocal circuits are formed using human IPSC-
derived neurons grown in proprietary microfluidic culture platforms (XonaTM) that enable the bidirectional growth
of axons between two distinct compartments and mimics the three dimensional and multi-cellular features found
in vivo; it also reproduces the dynamics caused by both outgoing projections and inputs from other brain regions.

Public health relevance
Project Narrative Chronic heavy alcohol use and Alzheimer’s disease (AD) alter brain metabolic function, neuronal activity and promote neurodegeneration. Heavy alcohol increases AD risk, and rodent studies implicate microglia in neuronal dysfunction. Using cutting edge 3D human reciprocal neurocircuits, we propose to determine if a microglia dysregulation of neuronal metabolism increases neuronal activity and degeneration to promote pathology alcohol- and AD pathology in human brain.